Photoactivation of Supramolecular Hosts: Novel Chemical Reactivity Through Photocatalytic Formation of High-Energy Intermediates in Host Microenvironments

Project Summary
Organic synthesis is a rate-limiting factor in drug discovery, and the chemical space that can be accessed
by medicinal chemists is limited by the synthetic methods available to access targets of interest. The
development of novel synthetic methods for constructing organic molecules with distinct architectures has the
potential to enhance human health by enabling the synthesis and discovery of new small molecule drugs.
Supramolecular host catalysis has proven to be a unique synthetic approach which can enable novel chemical
reactions that are not observed in bulk solution. In this approach, substrates encapsulated within supramolecular
hosts can engage in host-guest binding interactions that induce distinct reactivity and product selectivity in both
intra- and intermolecular transformations. Significantly, supramolecular host-guest binding has been found to
promote size-, site-, regio-, and enantioselective reactions. Building off work by the Toste, Raymond, and
Bergman groups studying the reactivity of supramolecular host assemblies, the objective of this proposal is to
design and develop supramolecular hosts that function as photocatalysts to induce novel photochemical
reactions that afford access to oxygen- and nitrogen-containing heterocycles in a highly selective manner. Prior
work by the Toste lab has established that stoichiometric quantities of a dodecanionic GaIII-centered tetrahedral
host assembly can engage in photoinduced single-electron transfer events with encapsulated substrates to
enable a radical rearrangement reaction. This established photoactivity of tetrahedral host assemblies will be
explored in two orthogonal approaches for the development of new host-catalyzed photochemical reactions. The
first approach develops supramolecular photocatalysts that perform single-electron transfer to encapsulated
substrates. Through the design of supramolecular assemblies with modulated redox potentials and tailored
microenvironments, new supramolecular hosts will be developed and applied as photocatalysts to facilitate
radical cyclization reactions that afford oxygen- and nitrogen-based heterocycles. The second application will
apply pyrene-based supramolecular hosts as photocatalysts to perform triplet energy transfer to azides,
generating encapsulated triplet nitrene intermediates. Through coencapsulation of triplet nitrenes with suitable
coupling partners, these hosts will be applied to promote intermolecular reactions of nitrenes to afford nitrogen-
based heterocycles and other nitrogenated molecules with chemoselectivity and site selectivity. As nitrogen- and
oxygen-based heterocycles are privileged scaffolds in medicinal chemistry, it is expected that these proposed
methods will have a positive impact on human health by aiding chemists in the synthesis of new small molecules
for drug discovery efforts.

Public health relevance
Project Narrative Synthetic methodologies limit the range of compounds that can be designed and prepared experimentally for small molecule drug discovery, and consequently the development of new synthetic methods can aid scientists in the synthesis and development of new therapeutics. Supramolecular hosts possess well-defined microenvironments which engage in host-guest interactions with substrates, facilitating novel chemical reactivity and enabling the synthesis of architecturally distinct molecules with unique selectivity. This proposal describes novel applications of supramolecular hosts as photocatalysts to synthesize medicinally relevant molecules with distinct product selectivity, chemoselectivity, and site selectivity.